Path B Missouri's Produce Safety Program

Missouri Department of Agriculture
The FDA's Cooperative Agreement Program for States and Territories to Implement a National
Produce Safety Program PAR-21-174
Project Period: 2021-2026
Abstract/Summary
The Missouri Department of Agriculture (MDA) is dedicated to the promotion and protection of
the state's agriculture industry. A 2017 MDA and Missouri Farm Bureau-funded economic
impact study determined that agriculture is the state’s number one industry with more than 88
billion dollars of annual economic impact. According to 2017 NASS data, Missouri has produce
grown on roughly 3,077 of farms. It is estimated that 95% of these produce farms will not be
covered by the FSMA Produce Safety Rule since their sales do not exceed $25,000 or the farm is
eligible for a Tester-Hagan Qualified Exemption.
The Department is well positioned to continue the development of the Produce Safety Program
begun in 2017 under the first FDA Cooperative Agreement for Produce Safety and help growers
achieve compliance with the Food Safety Modernization Act (FSMA). The Produce Safety
Program clearly supports the Department's mission "To serve, promote, and protect the
agricultural producers, processors, and consumers of Missouri's food, fuel, and fiber products."
The Department will pursue “Path B” as outlined in the Funding Opportunity Announcement.
The intention is to oversee both outreach and regulatory activities, enforcing the Produce Safety
Rule solely under FDA authority.
An inventory of farms is critical and methods for capturing the Farm Inventory were carefully
considered so that it can be gathered, maintained, and shared in a manner which supports an
integrated food safety system. The Program will continue to track all Farm Inventory data in the
WinWam database since this software program has integrated well with the outreach and
inspection objectives of the Program.
Throughout the grant period, the Department will continue to partner as appropriate with
Extension at the University of Missouri to provide training to producers. This outreach relies on
seasoned educators working to emphasize key components of the Produce Safety Rule. It allows
the Department to 1) “educate before we regulate”, 2) achieve greater compliance with the
Rule, and 3) minimize the risk of food borne illness no matter who grows the produce.
Finally, the Department has designed and implemented a compliance program to regulate
growers covered by the Produce Safety Rule. It is a cooperative effort with other regulatory
programs within the State, with other states, and in partnership with FDA.

Public health relevance
Missouri Department of Agriculture The FDA's Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program PAR-21-174 Project Period: 2021-2026 Project Narrative During the four years the Missouri Department of Agriculture participated in the first Produce Safety Cooperative Agreement, we have seen much progress as a result of building strong working relationships with sub-awardees, sister agencies, auctions, produce brokers, and growers. Our thorough outreach has included many Produce Safety Alliance grower trainings, technical assistance, brochures, and helpful promotional items like clipboards, buckets, and templates for keeping records. The initial inspections for Large and Small growers went well and we are looking forward to continuing to build our compliance program in an effort to protect consumers and support growers.